Investigating tumor-mesothelial cell interactions during ovarian cancer metastasis

PROJECT SUMMARY
Ovarian cancer is the leading cause of gynecological cancer-related deaths. The propensity for metastasis is a
driving factor for the poor outcomes associated with this disease, but there is yet to be an effective therapy
targeting metastasis. Ovarian cancer frequently metastasizes to the peritoneal cavity, where it attaches to
mesothelial cells surrounding the organs of the peritoneum, displaces this layer, and invades into the
underlying stroma. Mesothelial cells become active participants in this process, depositing and remodeling
extracellular matrix to which tumor cells can adhere. Mesothelial cells therefore offer a promising therapeutic
target. However, the manner in which they become permissive to metastasis is not yet fully understood.
Preliminary work from our lab suggests that mesothelial cell expression of the receptor tyrosine kinase
Discoidin Domain Receptor 2 (DDR2) promotes metastasis. After injecting mouse ovarian cancer cells into
mice, mice in which Ddr2 is globally knocked out demonstrate significantly decreased tumor burden compared
to wild type mice. Further, in vitro preliminary data suggests that inhibition of mesothelial cell DDR2 decreases
tumor cell clearance. Additionally, inhibition of mesothelial DDR2 decreases protein expression of the
mesenchymal transcription factor SNAI1, and transcription and secretion of mesenchymal associated protein
MMP-2, even in the absence of collagen - the ligand of DDR2. This proposal aims to 1) determine the
mechanisms by which mesothelial DDR2 expression contributes to ovarian cancer metastasis and 2) define
the effects of collagen-dependent vs. collagen-independent DDR2 signaling in mesothelial cells during the
steps of metastasis. Through testing an in vivo mesothelial-specific Ddr2 knockout mouse that I have
generated (Aim 1) and identifying collagen-independent mechanisms by which DDR2 expression contributes to
metastasis (Aim 2) this proposal will test the hypothesis that DDR2 acting in mesothelial cells creates an
environment permissive to ovarian cancer metastasis in the peritoneal cavity. In the long run, this proposal can
contribute to the development of new therapeutics that improve outcomes, delay metastases, and prolong life
in patients suffering from ovarian cancer. In addition to expanding our understanding of the mechanisms by
which ovarian cancer metastasizes, this proposal will foster the development of new skills to lay the foundation
for a lifelong career in the study of cancer biology.

Public health relevance
PROJECT NARRATIVE Ovarian cancer is a devastating disease with poor outcomes marked by frequent and widespread metastasis, but there are currently no effective therapies targeting this process. This proposal aims to deepen our understanding of mechanisms underlying metastasis by examining peritoneal mesothelial cells, key contributors in the metastatic process. By investigating the role of the receptor tyrosine kinase DDR2 in mesothelial receptivity to metastasis, we hope to identify novel therapeutic targets that can provide improved outcomes and longer lives for the many women affected by ovarian cancer.